Pseudouridine-mediated branch site recognition/selection during pre-mRNA splicing

We propose to solve two long-standing problems in the field of pre-mRNA splicing: (1) how does the branch
site recognition region (BSRR) of U2, which is a single unique sequence, recognize (via base-pairing) a
variety of branch site sequences (BSS) in pre-mRNAs during splicing? And (2) how does the pseudouridine
(Ψ), which is abundantly present in the U2 BSRR, contribute to this recognition? To address these questions,
we recently developed a screening system, allowing us to screen a library of pre-mRNAs with randomized
BSS sequences, under various genetic backgrounds where the numbers and combinations of Ψs in the U2
BSRR are manipulated and controlled. Our initial screen has generated exciting preliminary results, placing us
in a unique position to solve the aforementioned long-standing problems. Three specific aims are proposed.
1. To expand the list of BSS and its 5' adjacent sequences recognized by different U2 variants
We will build on our preliminary results and continue to screen the library (randomized BSS). Given that we
have also shown in our preliminary experiments that a 6-nucleotide sequence 5'-adjacent to the BSS in pre-
mRNA is also recognized by the U2 BSRR, we will screen additional libraries of pre-mRNAs with this 5'-
adjacent sequence being randomized, under different U2 (differ in Ψ) backgrounds. In doing so, we expect to
obtain a long list of BSS and its 5' adjacent sequences selected by different U2 variants with different
numbers and combinations of Ψs in the BSRR, thus helping decode how Ψs contribute to BSS recognition.
2. To evaluate whether/how Ψs within the U2 BSRR contribute to BSS selection / gene expression
With the BSS and its 5' adjacent sequences handy, we will search for the selected sequences in naturally
occurring pre-mRNAs. The splicing efficiency of these pre-mRNAs will be tested under U2 variants (differ in
Ψ). In doing so, we can link Ψ in the U2 BSRR to splicing/gene regulation. We also expect that some U2
variants prefer one BSS+5' adjacent sequence over another, whereas other U2 variants have completely
opposite preference between the same two BSS+5' adjacent sequences. We will create several constructs
with two BSS+5' adjacent sequences being placed in parallel, and test the usage of one BSS over the other
during splicing under specific U2 backgrounds, thus linking Ψ-mediated BSS selection to alternative splicing.
3. To dissect how individual U2 RNA variants recognize various BSSs and their 5'-adjacent sequences
Due to incomplete pseudouridylation at any given site, there exists a mixture of U2 variants (differ in Ψ) in
cells. We will dissect, in detail, how the mixture of U2 variants individually recognizes a specific BSS during
splicing. We will use the Oxford nanopore technology to quantitatively map, at single molecule level, Ψ in the
BSRR of U2 isolated from the spliceosomes, which are assembled onto a pre-mRNA with a specific BSS+5'
adjacent sequence. In doing so, we can assess how each individual U2 variant behaves, in a natural context,
in the process of BSS recognition. A complete picture of Ψ-mediated BSS recognition is expected to emerge.

Public health relevance
Relevance We propose to address how a variety of pre-mRNA branch sites are recognized by U2 during splicing/alternative splicing. To this end, we will use a screening system recently developed in our lab to screen, under various U2 backgrounds (differ in the number and combination of Ψs), several libraries of pre-mRNAs with the branch site sequence randomized. Our screen will generate a large amount of data, thus helping crack the code of how Ψs in U2 snRNA contribute to branch site recognition. Given that there are an increasing number of incidences that link splicing regulation and/or alternative splicing to diseases, we believe that our proposed work is also of clinical relevance.